Mechanisms of HBV cccDNA transcriptional regulation in persons with and without HIV

Hepatitis B virus (HBV) infects >300 million people chronically and is the leading cause of end-stage liver
disease and hepatocellular carcinoma (HCC), resulting in ~1 million deaths annually. HIV is a common co-
infection in people with chronic hepatitis B (CHB) and worsens HBV and liver disease outcomes. Liver disease
is a leading cause of death among PWH in the era of antiretrovirals, mostly due to viral hepatitis. Antiviral
treatment with nucleos(t)ide analogues (NUCs) suppresses plasma HBV DNA but does not eliminate the
covalently closed circular DNA (cccDNA) HBV template that resides in every infected cell. NUC interruption
leads to HBV DNA rebound and clinical hepatitis. Therefore, finding an HBV cure is of major importance for
HBV mono- and HIV/HBV co-infection.
In the first funding cycle, we applied single-cell methods to HBV/HIV co-infected liver tissues and demonstrated
that cccDNA is transcriptionally suppressed during NUCs. We now propose to understand the mechanism
underlying this finding since permanently exploiting this mechanism therapeutically can lead to a functional
cure. We propose an intensive study of NUC-associated cccDNA transcriptional suppression comparing
people with HBV/HIV co- and HBV mono-infection. In aim one, we will quantify intrahepatic viral DNA and
RNA quantities in hepatocytes from HBV mono- and HBV/HIV co-infected individuals using single-cell laser
capture microdissection and our novel droplet digital PCR assays. We will quantify and compare the cccDNA
transcriptional index (cccDNA TI), a measure of cccDNA transcription, in HBV mono- and HBV/HIV co-
infection. In aim two we will use novel techniques to test whether cccDNA transcriptional suppression is due to
genetic or epigenetic modifications of HBV using HBV mono- and HBV/HIV co-infected liver tissues from aim
one. We will use Cas9-Nanopore sequencing to examine epigenetic modifications of CpG dinucleotides in
cccDNA. We will use the NovaSeq platform to perform next-generation sequencing of cccDNA to look for
mutations that may be associated with reduced transcription and to quantify global cccDNA transcriptional
suppression of canonical viral genes and splice variants. In aim three we will test the hypothesis that the host
response contributes to cccDNA transcriptional suppression and compare this response between HBV mono-
and HBV/HIV co-infection. We will apply the novel 10X Visium spatial gene expression analysis (10x VSGEA)
platform to liver tissue from Aim one to compare hepatocyte host transcriptomes in tissues with high vs. low
cccDNA TI, directly interrogating HBV transcription using the same platform. We will confirm genes identified
with 10X VSGEA using Tecan RNA sequencing, enriching for cells with high vs. low cccDNA TI. We will
conduct in vitro studies to prove that genes of interest are associated with cccDNA transcriptional suppression,
focusing on innate immune genes and HIV-associated immune activation. Our proposal fills knowledge gaps in
understanding how to transform reversible cccDNA transcriptional suppression to a functional cure.

Public health relevance
Hepatitis B virus (HBV) infects >300 million people worldwide, is the leading cause of liver-related death, is worsened by HIV, and is very difficult to cure. We have evidence that HBV-infected people who are receiving treatment show diminished expression of HBV genes, which is an unexpected observation. We propose using new techniques to uncover how diminished expression happens and comparing this process in people with only HBV to those with HIV and HBV.